3T MRI scanner for Advanced Brain Imaging

Abstract
This proposal request funds to purchase a research-dedicated, state-of-the-art 3T MRI scanner
for neuroimaging to be used by a core group of NIH-supported investigators at the University of
Arizona (UA). The new scanner will support many active research programs that are
developing and/or using state-of-the-art MRI in their study of the brain. The proposed Siemens
3T Magnetom Prisma (Prisma) will significantly improve the capabilities for brain imaging at UA,
and provide enhanced data and image quality for advanced techniques in diffusion, functional,
and structural MRI. With the identification of neuroscience as a UA Health Sciences focus area,
represented by multiple centers and institutes, the UA has made strong institutional
commitments towards neuroimaging research with many new faculty being hired and new
buildings and facilities being constructed. The Prisma will be located in the Translational
Bioimaging Resource (TBIR), a new 20,000 GSF facility in the newly constructed Biosciences
Research Laboratory building. The TBIR houses multiple imaging modalities under one roof
and has the necessary infrastructure for human and animal imaging. The users of the new
instrument span a range of disciplines from biomedical engineering to psychology and
psychiatry to medical imaging to speech, language and hearing sciences. Neuroimaging cuts
across all of these disciplines and a powerful neuro-optimized 3T MRI scanner will further
advance the understanding of healthy and aging human brains as well as enable UA
researchers to deepen our understanding of, and develop treatments for, neurological disorders
including Alzheimer's disease, Parkinson's disease, traumatic brain injury, and stroke.

Public health relevance
Project Narrative A state-of-the-art 3T MRI scanner for neuroimaging will be acquired to support NIH-funded research aimed at understanding normal cognitive function as well as neurological disorders. The scanner will be administered within a core facility at the University of Arizona, serving neuroscientists and neuroimaging scientists across the entire campus.